Project 2

Project 2 ABSTRACT
Project 2 is a new Biomedical Research Project aimed at developing novel tools to rapidly
characterize pediatric respiratory health risks from exposure to hazardous volatile organic
compounds (VOCs). This work will be a critical element in the overall strategy of the Texas A&M
University Superfund Research Center to characterize and manage the human health risks
associated with exposure to environmental emergency-mobilized hazardous substances. Current
toxicity testing strategies do not account for developmental stage that is representative of the
pediatric lung or encompass human population variability, even though these factors (i.e., age, sex,
race, and genetics) are critical in asthma risk. Moreover, mechanisms of action underlying
individual/combined VOCs on asthma pathogenesis is poorly understood. To support the
evaluation of hazardous VOCs, including real urban mixtures, and elucidate mechanistic linkages,
Project 2 will test the hypothesis that the pediatric airway is distinctly susceptible to pulmonary
injury from hazardous VOCs, and that airway responses are modulated by extracellular vesicle
(EV)-mediated signaling. The research team brings together a toxicologist, a physician-scientist
and an atmospheric chemist to address the following specific aims. Aim 1 prioritizes the evaluation
of 20 individual Superfund-priority VOCs to test for asthma-related phenotypes in vitro, first using
a respiratory epithelial cell line (16HBE) cultured at air-liquid interface, and then in a populationbased,
age-appropriate model comprised of pediatric bronchial epithelial cells from the Developing
Lung Molecular Atlas Program. Next, representative designed mixtures matching environmentallyrelevant
proportions of chemicals in ambient air will be evaluated in the standard and populationbased
pediatric cell lines. These responses will inform aim 2 mechanistic studies, which will test
the hypothesis that VOC exposures alter EV protein expression, underlying respiratory dysfunction.
It is known that inflammation and epithelial barrier function are mediated by exosomes, a class of
secreted EVs ranging from 30 to 150 nm. In aim 2, EVs derived from 16HBE cells exposed to select
VOCs/mixtures will be purified and sequenced using a high-throughput proteomics approach.
Protein signatures revealed in this model will then be validated across a collection of pediatric donor
cell lines. Last, the functional role of VOC-exposed, cell-derived EVs will be evaluated using
adoptive transfer experiments. In parallel to aims 1 and 2, aim 3 objectives will characterize VOC
mixtures through mobile air monitoring across different locations in the greater Houston Area during
baseline and in response to environmental disasters. Additionally, to fill in gaps in disaster-related
toxicity testing, 16HBE cells will be directly exposed to ambient air onboard the mobile platform in
the field, using time-resolved measurements to drive conditional sampling of different air masses.
Outcomes from the studies proposed in Project 2 are highly relevant to the Superfund Program.
Overall, the novel tools and findings will improve basic understanding of mechanisms underlying
VOC-induced pediatric pulmonary injury and enable improved risk assessment to rapidly
characterize respiratory hazards that threaten children’s health.

Public health relevance
Project 2 Narrative Children living near Superfund sites are at high risk for inhalation exposures to hazardous volatile organic compounds (VOCs), especially following environmental disasters. Since mechanisms underlying the role of VOCs in asthma pathogenesis are poorly understood, this project will develop an age-appropriate, population-based in vitro pediatric airway model to rapidly characterize respiratory risks and determine the role of extracellular vesicles in response to VOC exposure. Using a state-of-the-art mobile air sampling approach, we will also characterize ambient VOC mixtures in high-risk communities to support real-world toxicity testing and disaster research response.